NRSA Training Core

Contact PD/PI: Urban, Randall J. NRSA-Training-001 (207)
J. NRSA Training Core (TL1)
Project Summary
The strategic objectives of our NRSA Training Core (TL1), which support the workforce development goals
of our CTSA hub, are to provide “predoctoral students orientation to translational science and postdoctoral
appointees advanced research training aligned with CTSA goals of advancing therapeutics (drugs, devices,
and preventatives), clinical interventions, and behavioral modifications to improve health”. These objectives are
being met by engaging trainees from diverse biomedical disciplines in an innovative, competency-based training
program, centered on the authentic clinical and translational (C&T) research practices of our Multidisciplinary
Translational Teams (MTTs). Existing curricula and training programs in the biomedical sciences at UTMB, as
elsewhere, excel at developing an individual’s discipline-specific knowledge and technical skills, but are less adept
at developing the core competencies needed to effectively participate in the interprofessional, multidisciplinary
team-based research environment critical to translate scientific discoveries into improvements in human health.
To address this gap, our Specific Aim is to produce highly skilled researchers who possess both an integrated
knowledge of the human diseases that underlie their C&T research and learner-level appropriate competency in
team management, leadership, conflict resolution and negotiations, interprofessional communication, stakeholder
engagement, entrepreneurship, and the regulatory/ethical issues associated with human-subjects research
and clinical trials. Since our program’s inception, trainees have engaged in a competency-based curriculum
using the latest pedagogical approaches, active learning modalities, and authentic experiences. Our current
TL1 curriculum includes: 1) the Interprofessional Translational Research Design (ITRD) Course, 2) a Team
Leadership Workshop for predocs; 3) the Clinical Encounters course, and 4) dissertation/postdoctoral research
projects co-mentored by both scientific and clinical experts. For this renewal application, we introduce several
new training initiatives including: new courses in medical-/bio-informatics and machine learning, team science
(e.g., TeamMAPPS) and community-engaged research, a bench-to-global health policy Vaccinology Track, and
new opportunities for training in entrepreneurship. Training will continue to be personalize through reiterative use
of the Individual Development Plan (IDP) by our trainees and mentors. In addition to tracking NCATS common
metrics, the outcomes of our training on learner competency across multiple C&T research domains will be
assessed using a robust set of rubrics and validated assessment tools. Results will continue to be disseminated
to the education and research communities through, on-line course materials, publications, presentations and
workshops. The need for well-trained C&T researchers with the knowledge and skills needed to advance new
scientific discoveries into improvements in human health has never been greater. With further support from NIH/
NCATS for 6 full-time training slots (4 predoctoral and 2 postdoctoral) and 10 short-term positions annually, we
will continue to prepare the biomedical workforce needed to solve the health care challenges of the 21st century.
Page 1273
Project Summary/Abstract
Contact PD/PI: Urban, Randall J. NRSA-Training-001 (207)
J. NRSA Training Core
References
1. Aguado D, Rico R, Sánchez-Manzanares M, Salas E. Teamwork Competency Test (TWCT): Astep
forward on measuring teamwork competencies. Group Dynamics: Theory, Research, and
Practice. 2014;18(2), 101-121. PMCID not required.
2. Levine CB, Ansar M, Dimet A, Miller A, Moon J, Rice C, Schaeffer A, Andersson J, Ekpo-Out S,
McGrath E, Sarraj H. Student Evaluation of Interprofessional Experiences Between Medical and
Graduate Biomedical Students. Journal of Research in Interprofessional Practice and Education.
2019;9(1). PMCID not required.
3. Chao C, Wooten K, Spratt H, Sarraj H, Aronson J, Hommel J, Hellmich M. Integration of leadership
training for graduate and medical students engaged in translational biomedical research: Examining self-
efficacy and self-insight. Journal of Clinical and Translational Science. 2018;2(1), 48-52. PMCID not
required.
Page 1274
References Cited